GENERAL CLINICAL RESEARCH CENTER

This is the 21st year of the continuation grant of the General Clinical Research Center at the University of New Mexico School of Medicine with its unique multi-ethnic patient population. Major areas of investigation are: Neuroendocrinology/Psychiatry: Examination of the hypophyseal/pituitary/adrenal axis in neuropsychiatric and metabolically altered states, depression, and post traumatic stress. Endocrinology: Molecular biology of aldose-reductase modulation of the polyol pathway in patients with diabetic complications, including status of oxidative stress on the development of diabetic complications. Metabolism: Determination of brain glucose utilization during normal and hypoglycemic states and its relationship to energy expenditure in man. Ketone kinetic investigation in diabetes in relation to insulin regulation and counter-regulatory hormone exposure. Investigation of glucose regulation in the elderly. Bioengineering: Development and evaluation of algorithms for the non- invasive infra-red glucose sensor. Development and evaluation of the fetal monitor by infra-red technology for pH, p02, and pC02. Nutrition: Longitudinal studies of the nutritional status of healthy elderly persons, studies of their intake, absorption. Neonatology: Role of Human Epidermal Growth Factor on pulmonary maturation in the perinatal period and regulation by corticosteroids; investigations of red blood cell and leukocyte kinetics and molecular regulation in the neonate during expansion with growth factors. Neurology: Role of matrix metalloproteinases in maintenance of the blood- brain barrier in injury, stroke and multiple sclerosis. Infectious Disease: Investigation of emerging pathogens, molecular biology of Hantavirus, Herpes Simplex Virus, and Human Papillomavirus. Pulmonary: Pathophysiology of functional pulmonary immunity in the human being.